“Two-hit” model for lymphatic malformations.

PROJECT SUMMARY
Complex lymphatic anomalies (CLAs) are rare diseases with variable clinical manifestations caused by the
abnormal development of lymphatic vessels. CLAs include central conducting lymphatic anomaly (CCLA),
generalized lymphatic anomaly (GLA), Gorham-Stout disease (GSD), and kaposiform lymphangiomatosis (KLA).
CLA patients exhibit a variety of phenotypes, such as tortuous dilated lymphatic vessels, multifocal lymphatic
malformations (LMs), and ectopic lymphatic vessels in bone. Unfortunately, existing treatments for CLAs have
significant side effects and are not effective in all patients. Therefore, there is an urgent need to identify new,
safer treatments for CLAs. We and others recently identified somatic activating mutations in KRAS in CLA
patients. To investigate the effect of hyperactive KRAS signaling on the development of lymphatic vessels, we
generated a novel mouse model that expresses an active form of KRAS (KRASG12D) in lymphatic endothelial
cells (LECs). We found that KRASG12D induces the formation of LMs in newborn mice but not in adult mice. These
results suggest that growing lymphatic vessels in newborn mice are more sensitive to the pathologic effects of
KRASG12D than stable lymphatic vessels in adult mice. Based on our preliminary data, we hypothesize that the
formation of LMs requires two signals - one triggered by a genetic mutation in LECs and another supplied by a
lymphangiogenic factor in the microenvironment. VEGF-C is a growth factor that stimulates lymphangiogenesis
during development and in pathological settings. In aim one, we will test whether VEGF-C in the
microenvironment renders lymphatic vessels sensitive to the pathogenic effects of KRASG12D. In aim two, we will
determine whether directly targeting KRASG12D reverses LMs. Completing these aims will establish that CLAs
are developmental disorders requiring a genetic mutation and a permissive lymphangiogenic environment for
their development. Thus, like tumors, oncogene-induced LMs require “two hits” for their formation. Our findings
will also significantly impact a broad spectrum of vascular and lymphatic malformations by identifying new
therapeutic targets and near-clinic drugs that could be repurposed for these disabling, disfiguring, and life-
threatening diseases. Importantly, KRAS mutation-specific inhibitors are predicted to have fewer side effects
than traditional targeted therapies, a feature that could improve patient compliance with treatment and overall
outcomes. We will also provide preclinical evidence for a new imaging modality that could rapidly move to the
clinic to image lymphatic function in CLA patients non-invasively.

Public health relevance
PROJECT NARRATIVE Complex lymphatic anomalies (CLAs) are life-threatening diseases caused by genetic mutations that impact the development of lymphatic vessels. The underlying pathogenesis of CLAs remains poorly understood, and existing treatments have proven ineffective for many patients. In this proposal, we will use clinically relevant animal models to explore novel pathophysiological mechanisms of CLAs and evaluate new treatments for this condition.